Characterization of HIV-1 Genome Dimerization: A Strain Specific Dimerization Mechanism

PROJECT SUMMARY/ABSTRACT
The goal of the proposed studies is to understand how HIV-1 sequence diversity impacts viral genome
dimerization, a requirement for viral replication. Like nearly all retroviruses, HIV-1 selectively packages two
copies of its full-length genome after the formation of a dimer – a process essential not only to packaging, but
also reverse transcription and recombination. The sponsor’s lab took a pioneering role in the structural
characterization of the highly conserved HIV-1 dimeric 5′-leader, the region believed to initiate genome
dimerization. Several outstanding questions remain regarding the mechanism and structures involved in the
process. Current proposals support a two-step mechanism beginning with a kissing-loop interface that then
matures into a more extensive intermolecular interface. While in vitro studies support this mechanism, most are
isolated to RNA fragments or ignore important cellular/viral factors. Studies of HIV genome dimerization are also
complicated by the enormous genome plasticity of HIV-1 that is driven by mutation and recombination, leading
to sequence diversity within the dimer interface. This diversity stratifies strains into two dimer classes, those that
are thermodynamically stable (nonlabile strains) and those that readily dissociate (labile strains). I will
characterize the differences between these two dimer classes by studying two model HIV-1 strains in the context
of the intact dimeric interface in solution, in cells, and in viruses: NL4-3 (nonlabile) and MAL (labile). Current
methods to study labile dimers are limited, as they readily dissociate in native gel electrophoresis assays;
therefore, suggesting a need to rely upon methods that will assess the equilibrium, solution state for each strain.
We will begin with a biophysical characterization of both strains, specifically characterizing the thermodynamics,
kinetics, and structures of the dimeric interface using Fluorescence Correlation Spectroscopy (FCS) and Nuclear
Magnetic Resonance (NMR) (Aim 1). Preliminary FCS data has shown our ability to monitor dimer formation at
concentrations and timescales previously inaccessible. Preliminary data using our 2H-edited NMR approach
suggest we can directly probe for intermolecular interactions in the full-length, dimeric HIV-1 MAL 5′-leader (>230
kDa), allowing us direct comparison with the previously characterized NL4-3 extended dimer. I will also compare
the dimerization process of these two strains in cells and viruses (Aim 2). We have now collected initial in vitro
data validating our novel fluorescent labeling strategy to discriminate intermolecular and intramolecular RNA
interactions that can now be applied in the context of viral replication in cells. We hypothesize that labile dimers
exhibit primarily a kissing dimer structure throughout assembly, highlighting a higher stability to the kissing dimer
than was previously thought, as well as implying the existence of a strain specific dimerization mechanism.
Successful completion of this project will also provide quantitative spatial and temporal characterization of HIV-
1 genome dimerization as RNAs are trafficked to assembly sites on the plasma membrane as well as allow us
to monitor changes in the dimer interface that potentially occur during virus assembly and maturation.

Public health relevance
PROJECT NARRATIVE Despite the existence of antiretroviral therapies (ARTs) that can keep the virus at bay for extended periods of time, there exist an actively growing population of HIV-1 infected patients as well as issues of compliance and resistance complicating current treatment. Therefore, there exists an active need to study HIV biology to identify therapeutic targets in areas currently less understood, which is why the focus of this study is RNA-related processes, specifically focused on genome dimerization. Successful completion of this proposal will give us a greater understanding of the mechanism of HIV-1 genome dimerization, a critical step to viral replication and genome packaging, while also clarify the role HIV-1 sequence variation has on this process.